Molecular Biology of Intestinal Lipid Transport /Metabol

[unreadable] DESCRIPTION (provided by applicant): [unreadable] The FASEB Summer Conference on the Molecular Biology of Lipid Transport and Metabolism will bring [unreadable] together scientists in a variety of related fields with the purpose of defining, describing and analyzing [unreadable] critical scientific problems and recent advances in an intimate and interactive environment. A key feature of this meeting is the opportunity to facilitate the interactions of students and postdoctoral fellows with senior established figures in the field. Such interactions have historically been successful in defining new research agendas and fostering scientific discourse and collaborations. This application requests partial funding for a Conference to be held July 15 to 20, 2006 at the Omni Resort in Tucson, Arizona. This will be the sixth such conference on this theme; the last one was held in the summer of 2003. This conference is unique in its highly multidisciplinary approach to study a key problem of mammalian physiology. Thus, we will bring together a diverse group of senior and junior investigators with expertise in the areas of nutrition, physiology, biochemistry, protein chemistry, cell and molecular biology, and developmental biology, to address recent advances in lipid metabolism and its regulation. The format will consist of seven major oral sessions scheduled over four days (four AM and three PM), an evening Keynote Address and two poster sessions. To date 26 highly noteworthy invited speakers have confirmed their willingness to participate. The seven formal sessions focus on active research areas: 1) Intestinal Sterol Trafficking; 2) Lipid Transport and Bile acid Metabolism; 3) Dietary Lipids in Extra-hepatic Tissues; 4) Fat Metabolism in Model Organisms; 5) Lipid Disorders with Multi-organ effects; 6) Nuclear Receptors with Lipid Ligands; and 7) Cell biology and Genetics of Lipid Metabolism. The ultimate session will be a key note address from Jeffrey Gordon on Intrinsic and extrinsic regulators of intestinal lipid metabolism. All participants will be invited to submit an abstract to one of two poster sessions that will be held during the conference in order to allow all attendees, especially students and junior investigators to present data and participate in discussions. Additional speakers will be chosen from the abstract submissions, and all participants will be encouraged to submit particularly novel late-breaking developments for brief oral presentation in the form of "hot topics". These hot topics sessions will be targeted specifically to accommodate junior scientists. In the past this conference has promoted interactions and scientific discussions among basic and clinical investigators from academia and industry. The limited attendance, state of the art scientific sessions, "hot topics" additions, and novel poster presentations combine to provide an essential forumthat will foster exchange of ideas and further scientific advances in a field where advances in basic research have historically been directly translated into improved therapeutic options for a large fraction of the population. [unreadable] [unreadable] [unreadable] [unreadable]